Research Experience and Training Coordination Core

CORE SUMMARY - RESEARCH EXPERIENCE AND TRAINING COORDINATION
CORE (RETCC)
The Research Experience and Training Coordination Core (RETCC) of the OSU SRP will integrate with all
other components of the Center to provide trainees with the intensive multidisciplinary training and
professional development necessary to support the research, research translation, and community engagement
goals of the Center. We will achieve these objectives in three Specific Aims: 1) Recruit a diverse cohort
of trainees to the OSU Superfund Program; 2) Prepare a skilled workforce with the core
competencies and multidisciplinary experience necessary to solve the complex issues
associated with PAH mixtures; and 3) Monitor, evaluate and report on individual trainee
performance and the overall success of the program. The centerpiece of our training program is the
implementation of Individual Development Plans (IDPs) for pre- and postdoctoral trainees. IDPs provide the
framework for an on-going evaluation that identifies professional development and experiential training needs
in the context of required core competencies and personalized short- and long-term education and career goals.
RETCC leadership, together with the Research Project and Core leaders, will help trainees to develop their
IDPs, articulate goals, identify and engage training opportunities, and assess progress. Trainee IDPs will
emphasize cross-training in complimentary disciplines across the spectrum of superfund-related biomedical
and environmental science and engineering research. RETCC leadership will engage the Research Project and
Core PI's and a diverse cohort of stakeholders and collaborators to ensure the availability of a wide-ranging
selection of state-of-the-art training activities including transdisciplinary coursework, seminars, workshops,
journal clubs, and experiential training and professional development modules. The RETCC will promote
interdisciplinary training and professional development by supporting new externships and collaborative pilot
projects. Individual IDPs will require trainees to participate in activities initiated by the CEC, RTC and DMAC,
to engage in leadership training and opportunities, and to deliver presentations at local, regional and national
conferences. RETCC leadership will coordinate, track (using NIH CareerTrac), and evaluate trainee
performance and the overall success of the program. We will communicate trainee and Core activities and
achievements with the Center and the SRP. The impacts of our training program will manifest in the
achievement of current Center goals and in the on-going and future contributions of a cohort of environmental
health scientists who solve complex, real-world environmental problems, especially those associated with
Superfund sites.